Photoacoustic imaging of endometriosis with nanoparticle contrast agents

PROJECT SUMMARY
Endometriosis is an incurable disease in which endometrial tissue grows outside the uterus, causing affected
women to endure pain during periods and/or sexual intercourse and suffer from reduced fertility and diminished
quality of life. Current treatments include anti-inflammatory drugs, hormonal therapies, and surgery (performed
alone or in combination with ablation to destroy the lining of the uterus), but none of these are adequate so
recurrence rates among patients are extremely high. Earlier diagnosis and/or improved resection of lesions
enabled by advanced imaging technologies may overcome the challenges associated with endometriosis
patient care. To address the critical need for better endometriosis visualization, we will develop inflammation-
targeted, light-responsive nanoparticles that can accumulate in endometriosis lesions (which are characterized
by high levels of inflammation) and serve as photoacoustic imaging contrast agents to visualize lesions with
enhanced sensitivity. This technology could be transformative as there are currently no reliable blood tests or
imaging techniques to accurately diagnose endometriosis, and improving image-guided resection could greatly
reduce recurrence.
To enable the nanoparticles (known as “nanoshells”) to target the inflammatory environment associated with
endometriosis, they will be coated with phospholipid membranes derived from macrophages. Previous
research has shown that various proteins present in macrophage membranes endow wrapped nanoparticles
with both immune evasion capabilities (due to “markers-of-self” like CD47) and inflammation-targeting
capabilities (enabled by proteins like PSGL-1, L-selectin, MAC-1, and others). Since endometriosis has high
inflammation, we expect that macrophage membrane-wrapped nanoshells (Mac-NS) will accumulate in lesions
more effectively than NS coated with the common passivating agent poly(ethylene glycol) (PEG-NS). In turn,
photoacoustic imaging mediated by Mac-NS should have higher contrast and superior sensitivity compared to
imaging mediated by PEG-NS. We will test these hypotheses in three aims, which will characterize the optical
and physicochemical properties of Mac-NS and PEG-NS (Aim 1), compare their ability to target endometriotic
versus non-diseased cells and enhance PAI contrast in vitro (Aim 2), and mediate the detection of
intraperitoneal lesions in mice without associated toxicity (Aim 3). Demonstrating this technology can improve
endometriosis visualization would be a major scientific breakthrough with potential for huge clinical impact.

Public health relevance
PROJECT NARRATIVE Endometriosis is an incurable disease involving abnormal growth of endometrial-like tissue outside the uterus. This project will evaluate the ability of inflammation-targeted nanoparticle contrast agents to accumulate in endometriosis lesions and enhance their detection under photoacoustic imaging. By enabling earlier diagnosis or facilitating image-guided resection of endometriosis lesions, this technology will overcome critical challenges in managing this devastating disease.